Open IPO and QA platform for conformal FLASH proton therapy

Project Summary
Lung cancer causes about 20% of all cancer deaths making it the most lethal cancer. For central lung cancer
(CLC), even the most conformal stereotactic body radiotherapy (SBRT) treatment plans inevitably overlap with
organs at risk (OARs) such as the lung, heart, esophagus, and central airways. This overlap incurs substantial
physical doses to these OARs, resulting in up to a 35% risk of fatal morbidity and guarded prognosis. Conformal
FLASH proton therapy holds great promise for toxicity reduction while maintaining tumor control, by combining the
advantages of (1) zero physical dose for OAR beyond Bragg Peak in proton SBRT, (2) 50% biological effective
dose (BED) reduction to OAR in ultra-high dose rates (UHDR), which is delivery of a hypo fraction dose at a dose
rate ≥40 Gy/s and (3) 30% more BED and greater immune response with more elevated linear energy transfer
(LET) in tumor. CLC needs all three advantages because OAR toxicities hinder physical dose escalation. Its clinic
translation needs UHDR in OARs and high LET in tumor but has two challenges: (1) if not optimized, elevated LET
in OAR can lead to an elevated OAR toxicity (2) quality assurance (QA) to ensure the micro timing structure and
microspatial LET, two critical factors impacting FLASH has not yet been developed.
Our integrated physical optimization (IPO) considers dose, dose rate and LET in the objective function. This
grant aims to establish an innovative platform of Simultaneous Intensity Energy Modulation and Compensation
(SIEMAC) optimization to inversely solve the variables (intensity and energy) of the IPO objectives and a QA system
that combines micro-timing/dose rate with micro dosimetry/LET. ADVACAM protype detector and commercial 2D
strip-segmented ionization chamber array (SICA) can meet the QA needs.
Aim 1: SIEMAC platform for CLC conformal FLASH. We will compare SIEMAC optimized plans with IMPT
plans using ten CLC patients involving different OARs (lung, heart, esophagus, and central airways). Based on our
preliminary data, the criteria are a >20% reduction in OAR BED or a >20% reduction in the irradiated volume for
heart at 5 Gy and lung at 20 Gy, relative to IMPT, maintaining target coverage. We will reoptimize these plans for
pulsed cyclotron and synchrotron beams to evaluate the impact of pulse structures over average dose rate.
Aim 2: QA platform to validate Monte Carlo (MC) calculated UHDR and LET. We will perform MC simulation,
3D print example passive energy modulation filters for three SIEMAC optimized FLASH fields. We will use
ADVACAM prototype detector to measure LET spectra and micro timing and SICA to measure dose rate under
conformal FLASH. Measured dose rates should agree within 5% of SICA. Measured LET spectra agreement with
MC simulation should be <5% via Bhattacharyya distances, a dissimilarity meter.
Innovation: The first test of SIEMAC to test its feasibility for CLC and QA scalability in clinic. Impact: We
will have an IPO treatment planning platform an immunotherapy conformal FLASH clinical trial of CLC and QA
platform for conformal FLASH to be adopted across different proton FLASH-capable machines.

Public health relevance
Project Narrative Conformal FLASH proton therapy holds great promise for toxicity reduction while maintaining tumor control, by combining the advantages of (1) zero physical dose for organs at risk (OARs) beyond Bragg Peak in proton stereotactic body radiotherapy, (2) 50% biological effective dose (BED) reduction to OAR in ultra-high dose rates, which is delivery of a hypo fraction dose at a dose rate ≥40 Gy/s and (3) 30% more BED and greater immune response with more elevated linear energy transfer in tumor. Central lung cancer (CLC) needs all three advantages because OAR toxicities hinder physical dose escalation. This grant tests Simultaneous Intensity Energy Modulation and Compensation optimization’s conformal FLASH feasibility for CLC and its quality assurance scalability in clinic.